Regulation of Growth and Morphogenesis

Project Summary
Our research investigates molecular mechanisms through which mechanical forces are regulated and
perceived, how biochemical and biomechanical signals are integrated, and how they act together to modulate
growth and shape during developmental, physiological, and pathological processes.
Planned investigations build on our discovery of a process that links cytoskeletal tension at adherens
junctions to regulation of Hippo signaling and tissue growth. This occurs through tension-dependent
recruitment of an Ajuba family LIM protein (Jub in Drosophila) to a-catenin. Jub then recruits and inhibits the
key Hippo pathway kinase, Warts, which leads to increased activity of the Hippo pathway transcription factor
Yorkie (Yki). We will investigate molecular mechanisms mediating this regulation, extending our recent
discovery of recruitment of Warts into phase-separated condensates with Jub and of a Jub-promoted
phosphorylation of the Warts N-terminus. Our research will test hypotheses regarding how these activities
contribute to inhibition of Warts and their relevance to regenerative and oncogenic stimuli that activate Yki and
its mammalian homologues. Our research on Hippo signaling will also extend our discovery that it modulates
Drosophila glial cell proliferation, focusing on how Hippo signaling is regulated in the glial cells that form the
blood-brain barrier in Drosophila.
Our research will also investigate how the cytoskeleton is regulated to drive morphogenetic processes.
Spectrins are membrane cytoskeletal proteins that influence cell shape and Hippo signaling. We discovered
that the Drosophila βH-Spectrin Karst (βH-Spec) can compete with myosin for binding to F-actin to influence
cytoskeletal tension. This raises fundamental questions that we will address regarding how and where spectrin
and myosin functions are integrated to modulate cell shape and behavior, including how the apically localized
βH-Spec and myosin compete and cooperate to influence normal development and physiology, how the
localization of βH-Spec and myosin are coordinated, and whether the laterally localized β-Spectrin similarly
competes with myosin for F-actin binding to modulate morphogenesis. We will also extend understanding of
Notch signaling functions by investigating how Notch regulates the cytoskeleton to create the dorsal-ventral
compartment boundary of the Drosophila wing disc.
Our studies investigate highly conserved proteins and signaling networks, and they are relevant to
understanding normal development and physiology, as formation of organs of characteristic and reproducible
size and shape is essential for organ function, and the symptoms of many congenital syndromes stem from
defects in organ growth or morphogenesis. Moreover, dysregulation of growth control is associated with
tumorigenesis, and a detailed understanding of organ growth, morphogenesis, and repair is required to create
functional organs from stem cells, which is a key goal of regenerative medicine.

Public health relevance
Project Narrative This proposal investigates mechanisms that control organ growth and shape, focusing on how mechanical forces experienced by cells influence developmental processes. Inappropriate growth during development results in organs that are incorrectly sized or shaped, causing birth defects. Controlling organ growth is also important for understanding how stem cells can be used to repair or replace damaged organs, and the inability to limit growth in mature organisms results in cancer.